Heat-Related Health Risk Assessment and Mitigation for Aging Populations in Public Housing: A Community-Individual Environment-Health Nexus

PROJECT SUMMARY
Although older adults in public housing face serious threats to their heat-related health, current assessment
and mitigation frameworks neglect physiological conditions and place-based infrastructural and social
inequalities. Our long-term goal is to develop quantifiable measures and dose-response relationships between
the density and characteristics of urban green infrastructure (GI) and heat-related health outcomes for older
adults, which can inform community planning and resilience policies that support aging in place during current
and future climate conditions. Our objectives are to: 1) assess heat-related health risks for older adults in
public housing neighborhoods; 2) determine the effects of green infrastructure on micrometeorological
conditions and heat stress; and 3) evaluate the extent to which neighborhood GI mitigates heat-related health
risks via emotional, cognitive, and social pathways. Our central hypothesis is that neighborhood GI
characteristics are associated with a reduced risk of heat-related illness for older adults in public housing. To
achieve Aim 1, we will perform heat-related health risk assessments using the population vulnerability
framework, which integrates exposure, sensitivity, and adaptive capacity. Biometeorological exposure will be
evaluated based on a novel human heat stress model that accounts for the physiology of older adults;
sensitivity and adaptivity will be assessed using social and infrastructural stressors. To achieve Aim 2, we will
develop 3-dimensional measures of GI characteristics using remote sensing data and street-level imagery and
video classifications and identify inter- and intra-neighborhood GI attributes that relate to micrometeorological
parameters and heat stress in older adults. To achieve Aim 3, we will conduct a 2-wave panel survey with
multi-stage sampling of older adults in public housing neighborhoods in Houston and Chicago. By comparing
baseline measures collected in the spring wave with those during heat conditions in the summer wave, we will
assess the sociopsychological pathways through which neighborhood GI is associated with heat-related
health/behavioral outcomes and subjective well-being. The research proposed in this application is innovative
because it develops heat-related health risk assessments that integrate a novel age-specific human heat-
stress model. It also focuses on GI as a modifiable risk factor and adopts a socioecological perspective to
elucidate the extent to which individuals’ interaction with their neighborhood’s green infrastructure can
moderate heat-related health risks via emotional, cognitive, and social pathways. The proposed research is
significant because it is expected to provide strong scientific justification for heat assessment and mitigation
frameworks that clarifies the complex transactions between the community-level socioenvironmental
infrastructure and an individual’s health. Ultimately, such knowledge has the potential to offer new public health
and environmental planning policies that enhance community resilience and promote climate equity.

Public health relevance
Project Narrative The proposed project will: 1) develop a novel human heat stress model based on physiological conditions of older adults and heat-related health risk assessments accounting for human heat stress and socio- environmental disparities experienced by older adults living in public housing, 2) elucidate the ambient cooling and biometeorological heat stress reduction effects of neighborhood green infrastructure characteristics, and 3) determine the sociopsychological mechanisms through which green infrastructure may buffer the adverse effects of heat exposure on health and well-being. The outcomes of this project will involve an age-specific heat stress model that can be used to assess population-level vulnerabilities and identified 3-dimensional green infrastructure attributes associated with reduced ambient heat and health risks via sociopsychological pathways. These outcomes will advance fundamental knowledge about the human-environment interaction related to heat exposure and heat-related health risks, as well as mitigation, in older adults, which is relevant to the NIH’s mission in enhancing health and preventing illness.